Genetic Analyses of bacteremia non-typhoidal Salmonella

Project Summary
There are at least 3.4 million cases of bacteremia with invasive non-typhoidal Salmonella
per year that result in 680,000 deaths1. Despite its significant cost on human health with a 20%
fatality rate, bacteremia caused by this pathogen is poorly understood. One important class of
virulence factors is ones that are anti-inflammatory. Traditionally, such genes were thought to
promote virulence by attenuating anti-microbial mechanisms such as intracellular killing and the
induction of apoptosis. My undergraduates surprisingly discovered that one of dozens of such
effectors, SpvC, is instead required for extraintestinal dissemination by interdicting the host's
ability to control the movement of infected phagocytes. They developed an in vitro cell c0-culture
assay that models the traversal of the blood vascular endothelium by phagocytes in the basal to
apical direction that before their work had only been observed with uninfected cells, a process
that immunologists refer to as reverse transmigration. The long-term goal of this work is to
develop new therapeutic intervention strategies for compartmentalizing infections, thereby
greatly reducing their chance of lethality. The short-term objective of this work is to characterize
how microbial and host factors regulate the extraintestinal dissemination of invasive non-
typhoidal Salmonella. In the first aim, with two in vitro models we will test a detailed molecular
mechanism that accounts for the ability of SpvC to promote movement. In the second aim, we
quantify how much each of the known pathways of extraintestinal dissemination contribute to
systemic disease and assess the role of SpvC in each. We hypothesize that the phosphothreonine
lyase activity of SpvC deactivates three MAPK kinases, to down regulate the host cytokine MIF,
which normally potently inhibits phagocyte movement. We will test if this prevents Salmonella
from disseminating through both the lymphatic system and the reverse transmigration pathways.

Public health relevance
Narrative It is unfortunate that the routes of extraintestinal dissemination available to enteropathogens are not clear as bloodstream infections with such microbes are responsible for millions of deaths per year. Here we will dissect what the various pathways, including the newest member, reverse transmigration, contribute to bloodstream infections with non-typhoidal Salmonella, which kills 680,000 people per year. Specifically, we will clarify the role of an anti- inflammatory effector that may attenuate virulence by manipulating the movement of infected host cells rather than their microbicidal activities.